Allosteric Regulation of Actin Capping Protein: Mechanism and Significance

Project Summary
Not applicable per solicitation.

Public health relevance
Project Narrative Not applicable per solicitation.